Type 1 Hybrid Implementation Effectiveness Cluster Randomized Trial of an mHealth Intervention to Help Parents Prevent Early Onset Alcohol Use.

Drinking before age 14, or “early-onset alcohol use” (EOAU), is a serious and highly prevalent risk behavior that often begins at home, with sips of alcohol provided by parents. By age 11, nearly one-quarter of U.S. children have already sipped alcohol. Our research has identified specific parenting beliefs and behaviors that are not being adequately addressed in family-based interventions. This research shows that many parents who provide alcohol have the mistaken belief that doing so teaches children how to drink in moderation; other parents report simply not having given thought to the risks. Even in the context of other protective factors, adolescents whose parents had permissive beliefs about alcohol use exhibited quicker escalations in alcohol involvement across adolescence than did those whose parents had less permissive beliefs. We developed and piloted an intervention program called Better Informed Parents Keeping Adolescents Safe from Alcohol (BIPAS), which is a universal, theory-informed, digital intervention for parents of incoming middle schoolers that is delivered via mobile devices. Findings from the pilot study demonstrated that BIPAS is highly acceptable to parents and can be delivered at low cost. Furthermore, preliminary results show that BIPAS is effective across a range of cognitive and behavioral outcomes, including parental provision of sips of alcohol to their children. Building on this research, the current application has the following aims. Aim 1: Expand the reach of BIPAS to by translating it into Spanish while maintaining fidelity to key intervention content; Aim 2: Use a rigorous national cluster-randomized trial with 2,000 parent-child dyads (N = 4,000 total) to assess the effects of BIPAS on EOAU, secondary outcomes (e.g., children’s alcohol use susceptibility), and hypothesized mediators that are the target of the intervention (e.g., parental permissive beliefs about adolescent alcohol use) relative to an attention control condition; and Aim 3: Evaluate implementation outcomes, including program reach, participant engagement and experience, and delivery cost. Aim 3 will include qualitative interviews to identify implementation supports that address factors that inhibit engagement. Across all aims, we will examine variability in mechanisms and outcomes across multiple dimensions, including parent language, educational attainment, and alcohol use status. By rigorously testing the effectiveness of a universal digital intervention with the potential for widespread reach, this study will provide novel evidence for reducing EOAU and its associated consequences. Furthermore, our findings regarding implementation supports for reaching families will provide insights into how best to support engagement more broadly across other digital parenting interventions.

Public health relevance
Many parents are permissive about children’s alcohol use (e.g., they allow sips of alcohol); this leniency increases the risk that children will experience serious alcohol-related consequences as they become teenagers. We have developed a promising digital intervention that teaches parents about their influence and provides skills and tools they need to discourage underage alcohol use. This application aims to evaluate the efficacy and implementation of our universal intervention for helping parents prevent early alcohol use.